Highly loaded long-acting depots of therapeutic peptides

Peptides can have exquisite potency and selectivity in treating disease, but suffer from rapid clearance.
Microparticle depot formulations, where the peptide is entrapped in a water-insoluble polymer matrix, have been
tested for decades to provide sustained therapeutic release for chronic disease. The traditional microparticle
structure has significant limitations, including low therapeutic content (<5 wt%) and inadequate release profiles.
Consequently, only 5 microparticle depots have been approved, representing 7% of marketed peptides. This
application seeks to develop a long-acting microparticle depot formulation using the inverse Flash
NanoPrecipitation (iFNP) platform being commercialized by Optimeos Life Sciences. iFNP enables the formation
of polymer-coated peptide-loaded nanoparticles in a scalable and continuous manner. These nanoparticles are
then clustered together to produce mechanically strong nanocomposite microparticles. The polymer coating
surrounding each individual nanoparticle allows for much higher peptide loadings and more controlled, sustained
release from the final microparticle.
The iFNP technology has been validated using a model peptide, liraglutide, with therapeutic efficacy
demonstrated in vivo for 1 month. The proposed research will apply the platform to three approved peptides that
currently lack long-acting formulations. The three peptides treat chronic disease and possess varying physical
properties. This proposed study will validate the universality of the platform and guide the selection of a lead
candidate for development:
1) Aim 1: Optimize encapsulation of three therapeutic peptide candidates in microparticle depots with
loadings above 30 wt%
2) Aim 2: Develop microparticle depots with sustained release profiles of active peptide over 1 month and
3 months with minimized peptide degradation.
The formulation design will build on the rules derived under an NSF STTR grant between Princeton University
and Optimeos. Peptides tested to date have all been chemically modified to increase circulation time. The
structure-encapsulation-release relationships identified in this work will advance our knowledge of suitable
candidates for formulation by the platform. Stability studies, using LC-MS analysis, will identify amino acid
residues with particular susceptibility to degradation that would be candidates for peptide modifications during
lead optimization of formulation candidates. Crucially, the proposed work will translate to the sustained delivery
of proteins, an application where no long-acting formulations are currently marketed.

Public health relevance
This Phase I SBIR develops long-acting depot formulations of three peptide therapeutics to reduce injection frequency from daily to monthly or quarterly. The formulation strategy addresses key limitations in current depot technologies, including low therapeutic loadings, high processing losses, and inadequate release profiles. This platform technology could be used to improve dosing schedules for a range of injectable therapeutics for chronic diseases.